Role of Rho Kinase in Diabetic Nephropathy

Project Summary
Diabetic nephropathy represents the primary cause of end stage renal disease (ESRD) in the US,
underscoring the need for innovative therapies for preventing its progression. We are interested in
understanding the cellular and molecular mechanisms that govern mitochondrial dysfunction in the diabetic
milieu with the expectation that understanding of these processes will expose potential disease mechanisms
and therapeutic targets in diabetic nephropathy. The present proposal is based on our recent published
observation, indicating that mitochondrial fragmentation is essential for prompting mitochondrial dysfunction in
podocytes in the diabetic milieu. A detailed understanding of mechanisms that govern mitochondrial fission in
the kidney remains incomplete and therapeutic targets based on these mechanisms do not exist. Because
dynamin-related protein-1 (Drp1) plays an integral part in regulating mitochondrial fission, we have focused on
investigating the role of Drp1 in mitochondrial fragmentation and progression of diabetic nephropathy. We have
been guided by our recent published observations that high glucose leads to mitochondrial fragmentation by
promoting Drp1 recruitment to the mitochondria. Deletion of Drp1 in db/db diabetic mice prevented
mitochondrial fission and improved histological and biochemical features of advanced diabetic kidney disease.
Importantly, we found that high glucose milieu triggers mitochondrial fission by phosphorylating Drp1 at serine
600 residue. Here, we propose to establish the crosstalk between phosphorylation of Drp1 and electron
transport complexes (ETC) as key mediators of mitochondrial ROS (mROS) and potential therapeutic targets
in diabetic nephropathy (DN). In support of our hypothesis, we have recently generated a novel diabetic
knockin mutant mouse harboring a single phosphorylation deficient (serine-to-alanine) point mutation at the
corresponding S600 site in the endogenous Drp1 allele (Drp1S600A). We observed that diabetic Drp1S600A
mice exhibited improved key biochemical and histological features of DN. To assess the role of Drp1S600
phosphorylation on mROS, We next crossed diabetic Drp1S600A mice with mice that express a redox-
sensitive green fluorescent protein biosensor (roGFP) specifically in the mitochondrial matrix (mt-roGFP) and
observed that Drp1S600A mutation in diabetic mice leads to reduced mROS in podocytes in live diabetic
animals. These findings provide compelling initial evidence into the unexpected role of Drp1 in a signaling
cascade that regulates mROS, and represents a therapeutic target that might be useful in preventing diabetic
kidney disease. Given these results and additional preliminary data presented in this application, this project
will address the hypothesis that Drp1 phosphorylation dynamically interact with mitochondrial ETC to enhance
mROS though a signaling network that is regulated by cardiolipin activation. The results of this study will
provide important new insights into the role of mitochondrial morphology in the development of diabetic
nephropathy, and may lead to novel therapeutic targets for the future treatment of diabetic kidney disease.

Public health relevance
Project Narrative Diabetes is the most common metabolic disease in the world and the leading cause of end stage renal disease. The focus of this proposal is to examine the pathogenic role of dynamin-related protein 1 (Drp1), a key protein involved in mitochondrial fragmentation, in experimental models of diabetic kidney disease. The results of this study will provide important new insights into the role of mitochondrial morphology in the development of diabetic nephropathy, and may lead to novel therapeutic targets for the future treatment of diabetic kidney disease.